PHASE I/II STUDY OF SIMVASTATIN (ZOCOR) THERAPY IN SICKLE CELL DISEASE

[unreadable] DESCRIPTION (provided by applicant): [unreadable] The numerous clinical complications associated with SCD are primarily attributable to sickle-induced vascular damage. The vasculopathy of SCD is characterized by endothelial injury due to the effects of hypoxia, increased shear stress, abnormal endothelial adherence of sickled red blood cells (RBCs), and inflammation induced by reperfusion injury. Growing evidence indicates that this vasculopathy also promotes angiogenesis, activation of coagulation, and disordered vasoregulation. Therapies targeted at the pathways contributing to endothelial injury may thus ameliorate the progressive vascular damage that occurs in SCD. [unreadable] [unreadable] The 3-hydroxy-3-methyl-glutaryl CoA (HMG-CoA) reductase inhibitors, also known as statins, are potent inhibitors of cholesterol biosynthesis and have been used extensively to treat patients with hypercholesterolemia. Recent clinical and experimental data indicate that statins modulate yet other pathophysiologic processes, many of which play a major role in the vasculopathy of SCD. Simvastatin has been shown to be well tolerated and safe in humans and appears to have significant nitric oxide (NO) enhancing effects in normocholesterolemic individuals. Numerous studies documenting the vasculoprotective effects of statins, together with preliminary data showing the therapeutic role of NO donors in SCD, provide a compelling rationale to investigate the potential clinical benefit of statins in SCD. [unreadable] [unreadable] Simvastatin has been extensively studied and marketed for use in other patient populations, making it readily available for treatment in SCD patients. However, data assessing the physiologic effects, safety and tolerability of simvastatin in SCD are needed prior to initiating randomized controlled trials to test the clinical efficacy of simvastatin. The investigators propose the following specific aims: [unreadable] [unreadable] 1. To determine the effect of oral simvastatin (Zocor) on vascular physiology in SCD, as measured by peripheral blood markers of endothelial injury. [unreadable] [unreadable] 2. To assess the safety and tolerability of oral simvastatin in patients with SCD. [unreadable] [unreadable] [unreadable]